ESRPS/NERO Egg Standards Workshop

Project Summary ESRPS/NERO workgroup will review and finalize the recommendations for Standards 1-10 that were submitted to FDA August 31, 2019 from Iowa and California.

Public health relevance
Project Narrative ESRPS/NERO workgroup participants will attend conference calls and workshop to finalize the recommendations for Standards 1-10 that were submitted to FDA August 31, 2019 from Iowa and California. Steps to complete the objectives are summaries in the research plan/conference plan.